Mentoring and Research in Cardiovascular Device Evaluation

PROJECT SUMMARY/ABSTRACT
Dr. Robert Yeh is Director of the Smith Center for Outcomes Research at Beth Israel Deaconess Medical
Center, where he leads a program devoted to advancing the evaluation of cardiovascular devices through
rigorously-conducted patient-oriented research. This grant will continue to support protected time for
mentorship of junior investigators while continuing the overarching goal of developing innovative approaches to
enhance the efficiency, fidelity and generalizability of cardiovascular device evaluation through the analysis of
unique multidimensional linked datasets. There is an urgent need to develop and implement more efficient
approaches to evaluate cardiovascular devices in representative patient populations. There is great
enthusiasm for exploiting newer study design and analysis strategies that can more closely approximate the
results of a desired but yet-to-be-performed randomized trial, while gaining the efficiency and
representativeness of using data routinely collected in the course of patient care. Applying state-of-the-science
methods to diverse and rich datasets may identify specific populations with different responses to device
treatment - a key step in the ability to deliver individualized patient-centered care. We will apply new methods
to transport inferences about treatment effects from pivotal randomized trials of high-risk cardiovascular
devices (including mechanical circulatory support devices in cardiogenic shock and drug-coated balloons for
treatment of coronary artery disease) to new target populations, representative of patients seen in
contemporary practice. We will further evaluate the safety and effectiveness of these devices through
application of the target trial framework, a set of conceptual and practical tools for designing observational
emulations of randomized trials that is well suited to overcome common forms of selection bias (e.g., immortal
time bias) in cardiovascular device comparisons. Finally, we will create a reusable prospective registry platform
which can be broadly used to evaluate newly approved medical devices efficiently and reliably. This research
will inform the safety and effectiveness of several cardiovascular devices that have not been well studied,
provide important clinical information to practicing physicians in the community, and create new standards for
the future regulatory evaluation of medical devices, while providing a fertile opportunity for mentorship for the
next generation of patient-oriented cardiovascular researchers.

Public health relevance
PROJECT NARRATIVE This grant will support protected time for Dr. Robert Yeh to provide mentorship for junior investigators interested in patient-oriented cardiovascular research, with the scientific goal to evaluate how the large amounts of data collected each day in the routine course of clinical care can best be employed to study commonly used devices to treat serious heart conditions. The study will use state-of-the-science approaches for data analysis to examine whether several high-risk cardiovascular devices are being used safely and effectively in the United States today, including among patient subpopulations that are rarely included in clinical trials. The results of this research will determine how ubiquitous data collected by registries, health systems and payers, and advanced causal inference methods, can best be combined to improve our present and future understanding of new medical devices.